RFA-IP-22-004, CORVETS - Cleveland Ohio Respiratory Viruses Vaccines Effectiveness across Traditional Risk Factors and Social Determinants of Health

Abstract
University Hospitals of Cleveland (UHC) proposes to join the US Platform Measuring Effectiveness of
Seasonal Influenza, COVID-19 and other Respiratory Virus Vaccines for the Prevention of Acute Illness in
Ambulatory Settings with its project CORVETS - Cleveland Ohio Respiratory Viruses Vaccines Effectiveness
across Traditional Risk Factors and Social Determinants of Health. This application is in partnership with Case
Western Reserve University and the Louis Stokes Cleveland VA Medical Center and includes
Components A, C, D and E. Through this partnership, the study team will be able to recruit from a racially
diverse source population and have access to innovative testing technologies.
The aims for Component A are to enroll and establish an electronic repository on at least 1,000
patients annually with medically attended acute respiratory viral illness (RVI) in the ambulatory setting
throughout the study period to measure the effectiveness of respiratory virus vaccines in children and adults on
laboratory ascertained medically attended acute respiratory illness presenting to an ambulatory setting. The
study team will establish and implement a comprehensive molecular diagnostic platform including viral
genomic sequencing of patients experiencing respiratory illness for underlying RVIs associated with influenza
(IFV) and COVID-19 to detect and catalog viral variants.
The aim for Component C is to identify individual level and household-level factors that contribute to
household transmission of SARS-CoV-2, influenza, and respiratory syncytial virus (RSV) and determine the
effectiveness of vaccination and antiviral treatment in preventing household transmission of SARS-CoV-2 and
influenza. To accomplish this aim, we will conduct a case-ascertained household transmission study to identify
individual-level and household-level factors associated with transmission.
Component D is a sample acquisition arm of the consortium that will obtain pre- and post-vaccination
samples for immunologic study by the study consortium’s designated laboratory. These samples can be used
to compare the immune responses measured in this component in the various subject groups with the with the
clinical observations noted in the Component A arm of the study on clinical vaccine effectiveness. The
component C activities aim to recruit and enroll 150 to 200 subjects who are eligible to receive specific
influenza and COVID-19 vaccines and obtain samples pre- and post-vaccination in addition to a
comprehensive and detailed history of prior vaccines, prior respiratory illness, past medical history, and current
medications. Component D studies enable us to gain a better understanding of how vaccines work in
vulnerable populations such as children and the elderly as well as in subjects receiving a variety of different
vaccination products and schedules.
The aims of Component E are to characterize and understand individual and population differences in
immune response to natural influenza infections using standard humoral and cell-mediated assessment and
systems biology methods, to characterize and understand the heterogeneity in immunogenicity to seasonal
influenza vaccines in the CDC/consortium-selected population groups of interest using standard and systems
biology methods, and to use standard humoral and cell-mediated assessment to characterize the
immunogenicity of the CDC/consortium-selected alternative influenza vaccine types and strategies, and to
report and mechanistically dissect these results via a systems biology approach.

Public health relevance
Project Narrative This study seeks to understand how well the Influenza and COVID-19 vaccines work in a real-world setting and how their effectiveness is changed by factors related to the person, the specific vaccine or the most common type of virus. The study also examines what affects who gets infected at home when someone has an infection, and what might change that. The researchers will also look into the body response to the infection or the vaccine to help understand what can be done to lessen the risk of getting an infection.